Training Grant in Transfusion Medicine

This is a renewal NRSA application (T32 HL69769, “Training grant in transfusion medicine”) requesting
continued support to maintain an effective and productive Transfusion Medicine Research Training Fellowship
at Emory University. Research in transfusion medicine is vital to the future of the field and, downstream, to the
safety of recipients of transfusion and cellular therapies worldwide. The Emory Center for Transfusion and
Cellular Therapies (CTCT) is one of the largest, most comprehensive academic transfusion medicine programs
in the nation and is dedicated to excellence in clinical service, outstanding basic, translational and clinical
research, and the clinical and research-based training of future leaders in the field. This T32 Post-Doctoral
Scientist Training Program is a critical element in both contributing to, and fulfilling the mission of, the Emory
CTCT. If funding is renewed, this grant would continue to provide salary support for two post-doctoral CTCT
Research Trainees per year for a 5-year period to participate in a highly structured, mentored training program
in transfusion medicine research. We aim to fill the acknowledged need for basic, translational, and
interdisciplinary research training in transfusion medicine. Such training is needed to develop future specialists
in transfusion, cell therapy and transplantation research in order to contribute to the further growth and
research development of the specialty and its ability to contribute to other fields of research and clinical
practice. Program strengths previously identified include: the Principal Investigator/Program Director; the
organization of the training plan as a small-scale program emphasizing high-quality candidates and research
projects; the involvement of senior faculty with strong scientific, funding, and training records; the provision of
specific mechanisms for educating fellows and externally evaluating the training program; and the academic
successes of previously-supported Fellows. To further underscore the program’s commitment to providing
direct personal effort in training post-doctoral research fellows, the faculty mentors have been limited to only
those with significant funding and proven track records in training early-career investigators. The Program was
initially funded in 2004, and renewed in 2009 and 2014. We are now applying for a third renewal to commence
in 2019. To date, 14 Fellows have completed the program, two Fellows are in the middle of training, and two
candidates have been identified to begin their fellowships mid/late-2019 should funding be renewed. Our T32
Fellows have been highly successful as evidenced by manuscript publications, faculty appointments, grant
support, and Steering Committee review. The Program Director greatly appreciates the funding that has been
provided to support this important training effort, and the time and effort volunteered by the reviewers in
evaluating this Fellowship.

Public health relevance
Transfusion medicine represents an important specialty that provides blood components and cell therapies for clinical use. Future improvements and developments in this field will lead to safer and more effective therapies. This training program will produce many of the future leaders who will spearhead these advances in transfusion and related therapies.